EVALUATION OF ELECTRICAL IMPEDANCE IN CEREBRAL ISCHEMIA

Further study was made of cerebral electrical impedance (CEI) during the phase of hypoperfusion. In the gerbil no substantial decrease in the CEI was found during this phase after a single 5 minute bilateral carotid occlusion. This was in spite of noticeable swelling of the brain and probable compression of the capillaries.